2023 Annual Meeting of the American Society for Investigative Pathology

The 2023 Annual Meeting of the American Society for Investigative Pathology (ASIP), will be held in conjunction
with the Tissue, Matrix, and Pathobiology conference from October 22-25 at The Grand America Hotel in Salt
Lake City, UT. This scientific conference is a collaboration between The Histochemical Society, the American
Society for Matrix Biology, and the ASIP. The Annual Meeting of the ASIP provides a unique forum for
presentation and sharing of cutting-edge research in experimental pathology. The target audience and subject
matter for the meeting are diverse, but united by a common focus on mechanisms of disease. Reflecting the
interests of the ASIP membership, the four-day scientific program for the 2023 Annual Meeting is comprised of
plenary sessions, major symposia, award lectures, workshops, guest society symposia, and special sessions
covering disease pathogenesis, biomarker development, prevention, diagnosis, and therapeutics, advanced
technologies, organ systems, and systems biology. This program contains strong components in cancer
pathobiology. Major cancer-related sessions will focus on: (i) Cancer Metabolism, Metastasis, and Therapeutic
Implications; (ii) Transcriptional Control in Cancer; (iii) Tissue Injury and Cancer Biology – Extracellular Vesicles
in Disease; (iv) The Intersection Between Breast Cancer and the Matrix; (v) Cancer Progression and Metastasis.
In addition, four meritorious award lectures will have a cancer-focus: (a) HPV and Cancer; (b) Diverse Functions
and Fates of Innate Immune Cells in Gut Inflammation and Cancer; (c) Epigenetic Control of Cancer Metastasis
and Immune Evasion; and (d) TIMPs: Emerging Roles in Tissue Homeostasis and Cancer Progression.
Additional opportunities for presentation of cancer-focused research will include abstract-driven minisymposia
and poster discussion sessions, which will intentionally feature young investigators and trainee scientists. The
program further provides a number of sessions focused on education and career development. These sessions
are designed for trainees and young investigators, but are open to all attendees. Education and career
development topics for 2023 include navigating challenging conversations, and enhancement of verbal and
visual communication skills. The ASIP regards promotion of the career development of trainee and young
investigators as an extremely important aspect of the Annual Meeting. Accordingly, the meeting provides not
only special events designed for their needs, but also sessions that highlight/showcase their work. Similarly, the
Program Committee works hard to ensure diversity among the participants with respect to gender, ethnic/racial
group, stage of career, and institutional affiliation. For 2023, among invited speakers: 39% are women, 39% are
Assistant/Associate Professors (or equivalent), and 100% of sessions include speakers that are women or
underrepresented. The sole specific aim of this application is to promote the participation of trainees and young
investigators in the 2023 Annual Meeting through provision of a Scholar Award program targeted to graduate
students, postdoctoral fellows, clinical residents/fellows, and junior faculty members.

Public health relevance
The Annual Meeting of the American Society for Investigative Pathology offers a unique forum for the sharing of original research results related to a wide spectrum of human diseases and disorders, with particular emphasis on the development, treatment, and prevention of cancer. Such sharing fosters more rapid advances in the understanding of human diseases such as cancer and accelerates the rate at which this knowledge can be applied to the development of diagnostic and prognostic tests, as well as targeted therapies. A major goal of the meeting is to provide educational and career support to young investigators who are interested in cancer biology and experimental pathobiology.